Developing methods and software for fitting the Cox proportional hazards model to partly interval-censored data

Title:
Developing methods and software for fitting the Cox proportional hazards model to partly interval-censored data
Abstract:
Partly interval-censored time-to-event data arise frequently in medical studies for diseases that involve periodic
examinations, such as cancer, HIV, infectious diseases, and diabetes. For example, progression-free survival
(PFS), the most commonly used primary endpoint in phase III cancer clinical trials, is actually partly interval-
censored as the time of death for a patient will be exactly known while the time of disease progression will be
only known to fall between two imaging assessment timepoints.
Due to the lack of well-developed methods and software, partly interval-censored data have been treated as
right-censored data for analysis in clinical trials and medical studies, which introduces bias at the very beginning
and may lead to invalid statistical inferences and erroneous medical conclusions. The proposed project contains
four aims: (1) to develop a Bayesian semiparametric method for fitting the Cox proportional hazards model, the
most commonly used survival regression model, to partly interval-censored data; (2) to develop a Bayesian
semiparametric method for fitting the Cox proportional hazards model with spatial frailty to spatially correlated
partly interval-censored data; (3) to develop a Bayesian semiparametric method for fitting a multiple-frailty
proportional hazards model with frailty selection to clustered partly interval-censored data; (4) then based on
the validated new methods, to construct an R package that is efficient, reliable, and user-friendly for medical
investigators to use. R is the most used statistical computing and graphics software and is free to the public.
Hence, such a tool will facilitate the search for effective new drugs and identification of risk factors, thereby lead
to improvement in patient treatment and disease prevention for many diseases that are significantly affecting
public health.

Public health relevance
Project Narrative Status quo of data analysis in clinical trials and other medical studies for partly interval-censored (PIC) data is to use the conventional right-censored approaches due to the lack of statistical methods and software for PIC data, which introduces bias and may lead to erroneous medical conclusions. In this proposal, we will develop a set of Bayesian semiparametric approaches for fitting the most commonly used Cox proportional hazards model to PIC data, spatially correlated PIC data, and clustered PIC data, and an R package implementing these approaches directly. This will provide biostatisticians and biomedical investigators with powerful tools to analyze PIC data that occur frequently in biomedical research where patients are examined periodically, such as cancer, HIV, infectious diseases, diabetes, and so on.